General Capillary to Arterial Endothelial Cell Transition in Pulmonary Arterial Hypertension

Title: General Capillary to Arterial Endothelial Cell Transition in Pulmonary Arterial
Hypertension
Project Summary
Pulmonary arterial hypertension (PAH) is characterized by a progressive increase of pulmonary
vascular resistance and obliterative pulmonary vascular remodeling that result in right heart hypertrophy,
failure, and premature death. The underlying mechanisms of loss of capillary endothelial cells (ECs) and
obliterative vascular lesion formation remain unclear. Our preliminary data showed that arterial
programing was evident in human PAH patients and rodents. We hypothesize that general capillary ECs
program to arterial ECs through HIF-2-Cdk19/Sox17/Notch4 signaling which contributes to the
pathogenesis of PAH. Completing our proposed study will provide a novel therapeutic strategy for the
effective treatment of PAH in patients.

Public health relevance
Project Narrative The proposed research is aimed at understanding why some patients develop high blood pressure in the lungs (pulmonary arterial hypertension, PAH). PAH is a serious and progressive disease with no cure and with 5-year mortality as great as 50%. In particular, we are trying to understand how the loss of capillaries and narrowing of arteries vessels happen and why they cause PAH development, and develop a new effective therapeutic strategy for the treatment of this devastating disease.